Strategies for targeting astrocyte reactivity in Alzheimer's disease and related dementias.

CORE A Supplement: Abstract-Summary
This supplement will operate under the umbrella of Core A of the parent P01 to support the generation of new
transgenic mouse lines in which genes-of-interest can either be expressed or knocked down (using doxycycline
inducible system) selectively in brain astrocytes. Two lines will be created for each research project (an “Astro-
on” and an “Astro-off” line) to target signaling constituents relevant to the reactive astrocyte phenotype and linked
to Alzheimer’s disease (AD) or AD-related dementias (ADRDs): MMP9 (Project 1), IRβ (Project 2), SLC1A2
(Project 3), and SUR2B (Project 4). New mouse models will significantly provide greater consistency in
terms of (1) the uniformity of astrocytes targeted and (2) the extent of overexpression/knock-down. This advance
is expected to reduce mouse-to-mouse variability and increase statistical power. New transgenic models will
also streamline study design by eliminating the need for injecting multiple AAV reagents (e.g. one AAV for
astrocyte targeting, another AAV for measuring Ca2+) in a single mouse at different time points. This advance
will greatly simplify data interpretation, while simultaneously reducing the number of invasive procedures per
mouse. Finally, new transgenic models will be readily available to the scientific community to verify our
findings or generate new avenues of research, which will promote experimental rigor and further delineate the
role of reactive astrocytes in ADRDs.

Public health relevance
OVERALL - NARRATIVE This P01 will use cell specific targeting approaches and cutting edge in vivo assessment techniques in preclinical mouse models— validated by biomarker measures in human subjects— to unravel the role(s) of reactive astrocytes in the pathophysiology of Alzheimer’s disease and related dementias.